Life's Essential 8, Digital Cognitive Markers, and Alzheimer's Disease Risk

PROJECT SUMMARY
Effective long-term drug treatments for Alzheimer’s disease (AD) remain elusive. Reducing major modifiable
lifestyle and clinical risk factors, quantified by Life’s Essential 8 (LE8), may delay symptom onset or progression.
The success of lifestyle intervention trials relies on the early detection of cognitive decline. Digital methods, such
as the digital pen (dCDT), voice recordings (dVOICE), and other smartphone or wearable measures, enable
easy, inexpensive, and frequent cognitive assessments in real-world settings, aiding early detection of cognitive
changes in large populations. However, no study has evaluated the use of digital cognitive markers for monitoring
cognitive changes in relation to longitudinal modifiable risk factors. It is urgent to address this knowledge gap.
The Framingham Heart Study (FHS), a multi-generational cohort, possesses various digital measures, including
dCDT and dVOICE measures collected from 2005 to 2014 (n~5000), digital Trail making and Stroop variables
via smartphone from 2020 to 2023 (n~ 700), and additional digital cognitive assessments and voice data via a
smartphone across the FHS generations from 2023 onward (n~5000). The FHS participants with digital cognitive
measures have undergone regular health exams that collected demographic, lifestyle, and clinical measures,
including those comprising the LE8, as well as longitudinal cognitive measures from standard cognitive tests,
MRI measures of brain aging, plasma amyloid-β 40/42 biomarkers, and the ApoE genetic markers. We previously
showed that several dCDT and dVOICE features are significantly associated with brain MRI measures, brain
amyloid-β, cerebral microbleed of mixed types, and incident dementia. Our long-term goal is to utilize the
relationship between longitudinal major modifiable risk factors and digital cognitive measures to monitor early
cognitive decline in AD progression. We hypothesize that studying the relationship between the longitudinal
LE8 metrics continuum and digital cognitive markers will effectively identify the major changepoint in cognitive
decline. This hypothesis is supported by our recent findings that AD is associated with two clinical risk factors in
LE8 in midlife but not in older age.6 To achieve the long-term goal, we will rigorously test the central hypotheses
with three specific aims: Aim 1. Compare cross-sectional and longitudinal LE8 associations of digital cognitive
measures (dNP) to conventional neuropsychological (cNP) test measures. Aim 2. Compare mild cognitive
impairment (MCI) definitions and severity levels in predicting AD. Aim 3. Identify the changepoint of accelerated
cognitive decline using LE8 metrics as during the preclinical phase of AD progression. The widespread use of
mobile and wearable devices makes digital cognitive assessments more feasible, efficient, and cost-effective
than traditional methods. Leveraging our expertise in digital neuropsychology and modifiable risk factors, our
research will improve understanding of digital cognitive markers for diagnosing and predicting cognitive health.
This includes monitoring cognitive health and examining how major modifiable risk factors relate to digital
cognitive measures for early detection of cognitive decline in Alzheimer's disease across diverse populations.

Public health relevance
PROJECT NARRATIVE This proposed study for the detection and progression of the early cognitive decline in Alzheimer’s disease (AD) will conduct statistical analyses with an existing, comprehensive data resource from the longitudinal Framingham Heart Study. It will seek to understand the relationship between major modifiable risk factors, quantified by Life’s Essential 8 (LE8), and digital cognitive measures as a way to monitor the early cognitive decline in Alzheimer’s disease (AD) progression. The findings from this study will add to our understanding of the diagnostic and prognostic performance of digital cognitive markers and provide solid evidence to support the implementation of digital cognitive assessment in large and diverse human populations for the early detection of AD with the widespread use of mobile/wearable devices.